Molecular targeting of DCLK1 signaling in hepatocellular carcinoma

Chronic liver diseases (CLDs) including cirrhosis of any etiology are the major risk factors for the development of
hepatocellular carcinoma (HCC). The national prevalence and mortality due to HCC in the US VA healthcare
systems have increased by 3-fold during the last decade. Despite HBV vaccination, improved screening methods,
and successful antiviral treatment for HCV, the incidence of CLD and cirrhosis has substantially (13%) increased
since 2000. The existing treatment options (radiation, chemotherapy, and immunotherapy) of unresectable and
metastatic HCC have not been successful in the majority of cases. Thus, HCC remains a significant healthcare
challenge. The fundamental goal of this proposal is to determine mechanisms driving the transformation process
and tumor growth in the liver, and develop strategies to improve clinical outcomes for these patients. In this quest,
we found that doublecortin-like kinase 1 (DCLK1) protein is highly expressed in chronic viral hepatitis, cirrhosis,
and HCC but not in normal liver. Elevated DCLK1 is associated with decreased survival of HCC patients. Recently,
we demonstrated that DCLK1 activates an atypical β-catenin(48 kDa)/TCF4 signaling in hepatoma cells. However,
its significance in the CLDs and HCC and DCLK1/β-catenin signaling axis in hepatic cell stemness is completely
unknown. Using a mouse model of HCC, we demonstrated that DCLK1 is heavily induced in hepatocytes at sites
of injury and likely contributes to the HCC-like tumor growth. Our preliminary data revealed that DCLK1-expressing
hepatoma cells can polarize Kupffer cells (KCs) into immunosuppressive M2-like macrophages. IL-10 secreted by
M2-like KCs has been reported to promote the selective apoptosis of M1 pro-inflammatory macrophages. Thus,
DCLK1-dependent M2 polarization has the potential to promote immunosuppression in the hepatic tumor
microenvironment (TME). Furthermore, inhibition of DCLK1 kinase activity resulted in a dramatic reduction in key
pro-inflammatory (TNFα, IL-1β) and immunosuppressive IL-10. These observations suggested that DCLK1 is a
central regulator of the complex interconnection of fibrogenic, immunoregulatory, and tumorigenic processes in
CLDs. Our central hypothesis is that DCLK1 is a key mediator of oncogenic signaling and immune dysregulation in
the tissue microenvironment in CLDs, which collectively stimulates the transformation of hepatocytes. We will test
this hypothesis with the following interrelated yet independent specific aims. Aim 1 will determine the mechanisms
by which DCLK1 mediates immunoregulatory and tumorigenic processes in the liver by introducing deletion and
point mutation in DCLK1 and assay for the functional impacts. We will use inhibitors to DCLK1 kinase (DCLK1-IN-
1) and β-catenin/TCF interaction (FH535) to verify DCLK1-regulated clonogenicity, CSC properties, and
monocyte/KCs polarization. Aim 2 will determine the effects of DCLK1 kinase inhibition on the DCLK1/β-catenin
regulated signaling axis, hepatic transformation process, and immune dysregulation in the HCC TME in a murine
model of cirrhosis/liver cancer. Finally, Aim 3 will define the role of the DCLK1/β-catenin axis in the regulation of
liver cancer cell stemness and tumor cell heterogeneity in a patient-derived tumor xenografts (PDX) model. The
results will be confirmed by the treatment of PDX tumors with DCLK1-IN-1, FH535, and in combination. In addition,
we will perform scRNAseq and phosphoproteomic analysis of the tumors to determine differential phosphorylation
in DCLK1+ tumor cells and DCLK1 signaling network mediated by phosphorylation. These studies will deepen our
understanding of DCLK1 regulation of a complex signaling axis contributing to hepatic tumorigenicity and
suppression of innate immune response in the liver tissues, which together drive HCC initiation and tumor growth.
In addition, the project will deliver potential anti-DCLK1-based approaches for the prevention and treatment of
HCC and cancers of other organs that rely upon DCLK1 functions.

Public health relevance
Project Narrative The national prevalence and mortality due to chronic liver diseases (CLDs) and hepatocellular carcinoma (HCC) in VA health care users have increased by approximately 3-fold during the last decade. Effective treatment for HCC represents unmet medical needs. Understanding the key mechanisms of liver disease progression to HCC will help develop effective treatments for these devastating diseases. This project will test the hypothesis that doublecortin-like kinase 1 (DCLK1)/β- catenin signaling axis is a key mediator of tumorigenesis and immune dysregulation in the tissue microenvironment of CLDs, which collectively stimulates the transformation of liver cells and modify innate immunity for supporting tumor growth. The proposed work will help define an attractive new anti-DCLK1 approach to prevent and treat HCC in US Veterans including the general public.